The Role of Mouse Zinc Transporter ZIP12 in Brain Development

Large gaps in knowledge about the causative mechanisms of neurodevelopmental disorders are significant
hurdles for prevention and possibly treatment. Thus, there is an unmet need to identify genetic and
environmental factors that place young individuals at risk for neurodevelopmental disorders. Importantly, it is
recognized that the genes that control nutrient metabolism can impact neurodevelopment through interactions
with both genetics and environment. The long-term goal of this laboratory is to identify nutrient metabolism
genes necessary for brain development and propose nutritional intervention strategies to prevent or ameliorate
cognitive deficits. Previous research from this laboratory has shown that ZIP12 is a zinc transporter that is
necessary for mouse neuronal development in vitro and Xenopus tropicalis frog embryogenesis and neural
tube closure in vivo. However, it is unknown whether ZIP12 promotes brain function and neuronal
development in mammals in vivo. The overall objective for this proposal is to establish that ZIP12 is a nutrient
metabolism protein that is necessary for mouse neuronal development and cognitive function in vivo, thereby
making it clear that ZIP12 (and the encoding gene, SLC39A12) is a candidate for inherited
neurodevelopmental disorders. ZIP12 knockout (KO) mice lacking a functional ZIP12 protein will be used to
achieve this objective. The central hypothesis is that ZIP12 KO mice have impaired brain zinc uptake, which
manifests early in life as a reduction in neuronal development and leads to reduced cognitive performance
lasting through early adulthood (and likely throughout life). This proposal will test this hypothesis through
studies designed to ask 3 specific questions. First, how does the loss of ZIP12 in mice affect brain zinc
metabolism (and other minerals)? Second, how does the loss of ZIP12 affect learning and memory? Third,
how does the loss of ZIP12 affect neurobiological development during the postnatal and early adulthood
periods? Completion of these studies will establish in a mammalian model that ZIP12 is a zinc uptake
mechanism necessary for proper brain zinc distribution to ensure optimal brain and cognitive function. This is
significant because genes that are necessary for brain function are candidate genes for inherited
neurodevelopmental disorders. The knowledge gained from these studies can lead to nutritional strategies for
promoting optimal brain development and function. Furthermore, these studies will reveal mechanisms of
genetic susceptibilities to neurodevelopmental disorders that are sensitive to nutritional deficiencies and may
be prevented through nutritional or pharmacological interventions.

Public health relevance
The goal of the current proposal is to determine how the zinc transporter protein ZIP12 is necessary for brain function and optimal brain development. Completion of the proposed studies will demonstrate how ZIP12 represents an example of how nutrients and genes interact to promote and maintain brain function during development. The knowledge gained from these studies may lead to nutritional or pharmacological strategies for preventing intellectual disabilities or neurodevelopmental disorders, particularly for individuals with genetic susceptibilities to nutritional deficiencies or related developmental disorders.